Cold Spring Harbor Laboratory Cancer Research Center

PROJECT SUMMARY - OVERALL
The overall goal of this Program is to understand how basic cellular processes are altered and co-opted by
cancer cells to promote tumor initiation and progression, and to apply this knowledge towards development of
new therapeutic approaches. During the past 46 years, the strong underlying basic science foundation of the
Program Project has allowed members to identify vulnerabilities in cancer and develop novel and highly
specific therapeutic strategies. This Program continues to take a multi-pronged approach grounded in basic
cancer research to identify and disrupt the molecular dependencies underlying cancer.
Within this Program, there are five highly integrated Projects (Chromosome Inheritance; Regulation of Pre-
mRNA Splicing in Tumorigenesis; Long Non-Coding RNAs and Cancer; Transcriptional Coactivators and
Enhancers In Human Cancer; Tumor Suppressor and Tumor Maintenance Genes) and four innovative Cores
that are using cutting edge technologies to study the molecular mechanisms of cancer biology. To achieve the
Program's goals, these studies will exploit novel animal models of human cancers, pioneering functional
genomics technologies, therapeutic antisense oligonucleotide strategies against otherwise undruggable
targets, and cutting-edge methods in biochemistry, cell biology and molecular biology. The researchers will
interrogate the basis of many of the most devastating types of tumors, including leukemias, breast, pancreatic,
and highly aggressive liver cancers. All of this work is supported by four Cores that provide access to
technologies, services, and expertise that all combine to enhance productivity and promote interactions.
The interactive and collaborative nature of this Program guides each of these Projects beyond their singular
potential. Research in all five Projects touches on overlapping themes and benefits from the expertise of the
other Program members. Together, this Program is making significant progress towards its goal of identifying
novel therapeutic targets that will substantially impact cancer treatment.

Public health relevance
PROJECT NARRATIVE - OVERALL Despite decades of research, cancer claims more than half a million lives in the US each year. Using innovative approaches and cutting edge technology, this Program Project aims to understand how basic cellular processes are altered as normal cells become cancerous. The insights gained through this research are likely to reveal highly specific, new vulnerabilities in cancer cells that will be the basis of innovative drug development in the fight against cancer.